Molecular characterization of extracellular vesicles for the spread of misfolded tau protein

Neurofibrillary tangles, composed of intracellular aggregates of hyperphosphorylated microtubule-associated
protein tau (tau), are by far the most correlated pathology for clinical symptoms of Alzheimer disease (AD).
Emerging evidence suggests that extracellular vesicles (EVs, such as exosomes and microvesicles), transfer
pathological tau between cells as vehicles, propagating tau pathology. It is urgently important to find the
molecular basis of brain-derived EVs, which may critically regulate EV uptake by neurons and aggregation of
tau protein in EVs and/or recipient neurons. We have recently established the method for isolating EVs from
human brain samples and successfully performed their proteomic profiling. We found that selective molecules
from the EV proteomics datasets were able to differentiate human AD-EV from healthy control (CTRL)-EV with
88% accuracy by machine learning analysis, confirming pathogenic character of AD-EV molecules.
Furthermore, our exciting preliminary data have shown that AD-EV have significantly higher tau seeding
activity compared to CTRL-EV by FRET sensor tau seeding assay with subsets of EV molecules showing
significant association with tau seeding activity. This proposed project will fortify these preliminary results and
find the converging or specific mechanisms among tauopathies for mediating tau aggregation and its seeding
via EV uptake through proteomics and biological examination of brain-derived EV samples. To meet this
challenge, we assembled a multi-disciplinary team of investigators who have a strong record of
accomplishments in biologic (Ikezu), proteomic (Emili) and bioengineering and bioinformatic analysis (Issador).
In Aim1, we will examine EV samples from 240 new brain specimens (40 AD, 40 CTE, 40 LBD, 40 PSP, 40
CBD and 40 CTRL) for precision mass-spectrometry-based proteomics and tau-interactomes, and analyze
those datasets by the machine learning approach. Aim 2 will examine the efficiency of tau propagation using
tau fibrils, oligomers and EVs isolated from the same donors of the 5 different tauopathies and control cases in
vitro and in vivo using FRET-based tau seeding assay and EV uptake by primary cultured mouse cortical
neurons in vitro. EV-associated tau will be further characterized by the biochemical and microscopy-based
analysis for their conformational and posttranslational changes. We will evaluate the difference in tau
propagation after the intracranial injection of the tau seeds from different tauopathy brains using our recently
established mouse models. Aim3 will identify candidate molecules most likely involved in EV uptake and tau
seeding activity by bioinformatic analysis of the proteome dataset (Aim 1) and biological datasets (Aim 2). We
will then test the functional roles of the identified molecules on EV uptake, tau seeding activities and neuronal
firing activities in vitro. The candidate molecules will be specifically targeted by gene silencing or antagonists
for their therapeutic potential to halt tau propagation in vitro and in vivo. Successful identification of responsible
molecules for tau propagation will serve as a foundation for understanding EV-mediated disease progression.

Public health relevance
We propose to achieve highly comprehensive characterization of the protein composition of extracellular vesicles in human brain tissues, and determine their emerging roles on enhancing neuronal uptake of vesicle associated tau and spread of tau pathology in human induced pluripotent stem cell-derived neurons. The candidate molecules will be specifically targeted by specific antagonistic reagents for their therapeutic potential for halting tau propagation in vivo. These studies will lead to a better understanding of vesicle-mediated disease spread mechanism in Alzheimer's disease and related tauopathy.